Dissemination of tools and methods for modeling state-dependent neural sensory coding

Project Summary
Throughout life, humans and other animals learn statistical regularities in the natural acoustic environment.
They adapt their hearing to emphasize the features of sound that are important for making behavioral
decisions. Normal-hearing humans are able to perceive important sounds in crowded noisy scenes and to
understand the speech of individuals the first time they meet. However, patients with peripheral hearing loss or
central processing disorders often have problems hearing in these challenging settings, even when sound is
amplified above perceptual threshold. A better understanding of the function of the healthy and impaired
auditory system will support new treatments for these deficits.
This project will develop computational tools to study central auditory processing. A software library will support
fitting and evaluating a large number of encoding models to describe the functional relationship between a
time-varying natural auditory stimulus and the corresponding neural response. Many such models have been
proposed, but relatively few direct comparisons have been made between them. This project will enable their
comparison, allowing identification of the key features that contribute positively to their performance. The
system will have a modular design so that useful elements from different models can be combined into
comprehensive models with even greater explanatory power. The software will be open source and will support
data from multiple recording modalities, including small-scale single unit electrophysiological and calcium
imaging data, as well as large-scale local field and magnetoencephalography data.
In addition to building on existing hypotheses about neural coding, the system will support machine learning
methods for fitting artificial neural network models using the same datasets. These large, data-driven models
have proven valuable for wide ranging signal processing problems, but their value and relation to existing
models for neural sensory processing remain to be explored.
Sensory processing involves coherent activity of large neural populations. To study coding at the population
level, the system will support models that characterize the simultaneous activity of multiple neural signals and
identifies latent subspaces of population activity related to sound encoding. Sensory coding is also influenced
by behavioral context, reflecting changes in behavioral demands and the more general environment. The
system will incorporate behavioral state variables into models, where encoding properties can be modulated by
changes in behavioral context.

Public health relevance
Project Narrative Patients with hearing impairments and central neurological disorders have difficulty processing and making accurate judgments about auditory stimuli, particularly in challenging noisy environments. We seek to understand how the neural populations in the healthy brain represent complex natural sounds. These experiments will provide novel insight into how the brain solves problems that can be used to develop new devices and treatments for these debilitating conditions.